Spike Timing Defects and State Representation Impairments in Nonhuman Primates

PROJECT SUMMARY: PROJECT 1
The purpose of PROJECT 1 is to use nonhuman primates to examine prefrontal local circuit and distributed
network impairments associated with state representation dysfunctions of relevance to individuals with
psychosis. PROJECT 1 will relate synaptically mediated functional interactions between neurons in prefrontal
networks to computations that support state representation processes. In Aim 1, we will quantify functional
neural interactions by measuring temporal correlations in the timing of action potentials (‘spikes’) imposed by
synaptic interactions between the neurons. In Aim 2, we will disrupt those interactions by pharmacologically
blocking NMDA receptors (NMDAR), which induces a period of transient cognitive impairment during which
monkeys commit similar patterns of behavioral errors during the DPX decision-making task as do people with
schizophrenia. We will record neural activity in prefrontal cortex and anatomically connected brain areas
(posterior parietal cortex and the dorsal striatum) concurrently during the period of cognitive impairment, while
monkeys perform the DPX and Bandit tasks, which allow us to index state estimation, state learning, and state
stability processes. We will discover how reducing NMDAR synaptic transmission alters functional interactions
between neurons in prefrontal networks, leading to computational failures in state representation processes.
To provide a bridge to neural signals that we can record in humans, we will record neural signals that reflect
brain activity at the microscale (single neuron action potentials), mesoscale (local field potentials within a
cortical area) and macroscale (local field potentials and EEG across cortical areas) from prefrontal cortex and
connected structures simultaneously. We will use causal discovery analysis to identify the parameters that can
be found with more limited neurophysiological techniques available in humans (for PROJECTS 3 and 4). As
PROJECT 4 identifies specific cognitive training regimens that improve state estimation and state stability in
individuals with early psychosis, PROJECT 1 will back-translate these paradigms to monkeys to identify
training-induced changes in attractor network parameters at the neurophysiological (micro-, meso- and macro-
circuit) levels.